Genetics Core

PROJECT SUMMARY – GENETICS CORE
The Genetics Core is designed to integrate cutting-edge genomic technologies into the research
programs of investigators, to enhance the understanding of Intellectual and Developmental
Disabilities (IDD) and develop future treatments. The translational mission of our IDDRC
includes supporting research aimed at identifying genetic causes of IDDs that will inform
prognostic information, recurrence risk counseling, monitoring for associated medical
complications, and supportive treatments. Further, we facilitate efforts to characterize
epigenetic, transcriptomic, and proteomic responses to environmental and genetic insults
involved in IDD pathogenesis using patient derived and genome-edited cellular and animal
models. Our translational mission has engendered the development of highly interactive service
components that both inform and enable these goals. The aims of the Core are to provide
support for: 1. IDD gene discovery through human subjects protocol development and IRB
approval, participant recruitment, consent, enrollment and sample collection (blood, saliva, skin,
urine), and targeted, exome, and genome sequencing for initial discovery and validation in large
cohorts; 2. Functional genomics of IDD biological mechanisms through expression arrays and
RNA-sequencing, chromatin structure and functional assays, proteomics and metabolomics,
and bulk and single cell analyses; and 3. Cell and animal models through genome engineering
to create cellular and animal models and evaluate phenotypes, iPSC creation, and
differentiation protocols for nervous system cell types and organoids.